Drugging NRF2 to improve radiation therapy in head and neck squamous cell carcinoma

The NRF2 transcription factor is active in more than 30% of head & neck squamous cell carcinomas (HNSCC),
owing to pathway activating mutations and mutation-independent mechanisms. NRF2 drives a gene expression
program that mitigates oxidative and electrophilic stress, reprograms and enables cancer cell metabolism, and
suppresses immune cell infiltration. In HNSCC patients, NRF2 activity portends a poor prognosis; its mutational
activation is predictive for resistance to radiation and local regional failure. Though frequently active in human
cancers, mouse models suggest that constitutive NRF2 activity is not sufficient for oncogenesis, but rather NRF2
synergizes with oncogenes and tumor suppressors to drive tumor progression. Despite great need, proven and
efficacious NRF2 therapeutic inhibitors do not yet exist in the clinic. This revised application is a response to
PAR-22-198, the Precision Approaches in Radiation Synthetic Combinations (PAIRS) program. We hypothesize
that chemical suppression of NRF2 activity will sensitize HNSCC to RT. Our previous functional genomic,
proteomic, and small molecule screens revealed therapeutic targets and pharmacological agents that suppress
NRF2 activation in HNSCC. Here we focus on two in vivo efficacious, potent and mechanistically distinct NRF2
chemical inhibitors. First, we previously reported the ANCHOR class of KEAP1 mutants which maintain
enzymatic activity for NRF2 ubiquitylation but fail to degrade the NRF2 protein. Working with Vividion
Therapeutics, we sought cysteine-reactive molecules to reverse the ANCHOR phenotype. This resulted in
VVD065, a highly selective and potent small molecule that induces NRF2 ubiquitylation, degradation and
radiosensitivity. Second, our drug screens discovered pyrimethamine (PYR), a FDA approved medicine, as an
efficacious inhibitor of NRF2 signaling. When administered to our genetically engineered mouse model (GEMM)
carrying an inducible activating NRF2E79Q mutation, PYR reversed esophageal and oral cavity hyperplasia with
no observed toxicity. Subsequent structure-activity-relationship optimization resulted in 30-fold more potent small
molecule we call WCDD115. Because NRF2 activity drives resistance to radiation therapy (RT), our primary goal
is to leverage these two novel NRF2 inhibitors as synthetic combination agents for RT in human and mouse
models of HNSCC. Importantly for this work, we recently reported the first NRF2-driven GEMM of spontaneous
oral SCC. Our proposed experiments use human HNSCC xenografts, mouse syngeneic tumor grafts, our NRF2-
driven oral cavity SCC GEMM, and human and mouse 3-D spheroid cultures to test if VVD065 or PYR/WCDD115
synthetically combine with RT to suppress tumor growth while minimizing toxicity to normal tissues. We will also
identify patient stratifying genotypes predictive of susceptibility to NRF2 chemical inhibition and RT sensitization.
Together, these studies will produce foundational data for the dosing, scheduling, efficacy and toxicity of NRF2
inhibitors as synthetic combination agents with RT in pre-clinical HNSCC models. The impact of this research
will be an improved response of HNSCC to radiation therapy.

Public health relevance
Human cancers of the head & neck (HNSCC) remain some of the most common cancers worldwide with dismal prognoses and limited therapies. Our work focuses on discovering and testing drugs that inhibit the NRF2 protein, which is active in many tumors and causes resistance to radiation and chemotherapy. In this application, we will test whether adding 2 promising new NRF2 inhibitors to standard radiation therapy will improve survival and outcome in preclinical cancer models, providing support to move these inhibitors into clinical trials for human patients.